Developmental Research Program

The objectives of the Developmental Research Program are to: 1. Identify innovative projects with significant potential for reducing bladder cancer incidence and mortality and increasing survival. 2. Encourage collaborations among scientists within and outside the SPORE environment. 3. Develop specific criteria for selecting and funding projects. 4. Establish a mechanism to ensure Developmental Projects achieve their translational research goals.